Defining the role of platelet-mediated glycocalyx breakdown in driving pathogenic CD8 activity during severe malaria.

Abstract
Malaria afflicted 247 million people in 2021, of which over 600,000 died. In the most severe cases, patients can
develop organ-specific pathologies related to vascular leak, including cerebral malaria and malaria-associated
acute respiratory distress syndrome (MA-ARDS). The mechanisms of pulmonary vascular leak are poorly
understood, and the long-term goal of this work is to define the molecular mechanisms underlying pulmonary
vascular leak in malaria to develop rationale therapeutics to treat this condition. It has been previously shown
that CD8 T cells and platelets are activated by Plasmodium in humans and are required for vascular breakdown
in mouse models, but specific mechanisms underlying how these cells incur damage is still unclear. The central
hypothesis of this proposal is that platelets contribute both directly and indirectly to MA-ARDS by promoting
CD8 cytotoxicity leading to barrier dysfunction. The rationale of this work is that identifying how platelets
augment the pathogenicity of CD8 T cells will provide new avenues for chemotherapeutic targeting of MA-ARDS.
Published work from the Lamb lab and preliminary data shown here demonstrate that mice deficient in platelet
a-granules (Nbeal2-/-) survive Plasmodium berghei infection and fail to develop vascular leak in the lungs and
brain. In intestinal colitis models, published work by the Petrey lab has demonstrated that platelet granule-derived
hyaluronidase 2 (HYAL2) is responsible for driving degradation of hyaluronan (HA) in the endothelial glycocalyx
(eGC), which serves as a key modulator of barrier integrity. Our preliminary data show that HA fragments in the
plasma, an indicator of glycocalyx breakdown, are increased in infected wildtype mice but not in platelet a-
granule-deficient mice. The literature shows that HA fragments can promote cellular activation and proliferation,
and our preliminary data demonstrate that the Nbeal2-/-, which have low plasma HA, have low CD8 T cell
accumulation in the lung during Plasmodium infection. The published literature and our preliminary data have
led us to form the working hypothesis that platelet cleaves the endothelial glycocalyx, promoting CD8 T cell
activation and recruitment via circulating HA fragments and exposing endothelial cells to CD8 effector molecules,
resulting in barrier damage. We will test this hypothesis with the following specific aims:
Aim 1: Demonstrate that platelet a-granule HYAL2 is required for eGC breakdown in MA-ARDS.
Aim 2: Test the hypothesis that plasma HA promotes pathogenic CD8 trafficking via CD44 binding.
We expect that the work proposed in Aim 1 will determine the mechanism by which platelet hyaluronidase
causes pulmonary vascular leak during MA-ARDS, which has not previously been described in malaria, and
demonstrate how the resulting plasma HA modulates CD8 T cell activation and trafficking. We anticipate that the
findings from this work will provide a much-needed deeper understanding of the mechanisms of MA-ARDS,
inform on potential mechanisms underlying vascular leak in other disease models, and give insight into potential
pathways that could be targeted therapeutically to disrupt MA-ARDS in the clinic.

Public health relevance
Project Narrative While vascular leak is a deadly complication of malaria, the mechanism underlying its development is poorly understood. The goal of this proposed study is to identify how platelet degranulation promotes vascular leak by driving endothelial glycocalyx breakdown and CD8 T cell activation/recruitment to the lung during severe malaria. This work is relevant to the NIH mission to develop fundamental knowledge that reduces human disease burden by defining a mechanistic pathway that could be targeted by novel adjunct therapies to disrupt the development of vascular leak in malaria.